KERATINS, WOUND REEPITHELIZATION, AND HAIR FOLLICLE CYCLING

Keratins are abundant proteins in epithelial cells, in which they occur as a cytoplasmic network of 10-12nm wide intermediate filaments (IPs). They are encoded by a large family of conserved genes in mammals,with > 50 individual members partitioned into two sequence types. A strict requirement for the heteropolymer- ization of type I and type II keratin proteins during filament assembly underlies the pain/visetranscriptional regulation of keratin genes. In addition, individual pairs are regulated in a tissue-type and differentiation- specific manner. Elucidating the rationale behind the diversity and differential distribution of keratin proteins offers the promise of novel insight into epithelial biology, in health and disease. Keratin IPs act as resilient yet pliable scaffolds that endow epithelial cells with the ability to sustain mechanical and non-mechanical stresses. Inherited mutations altering the coding sequence of keratins underlie several epithelial fragility conditions. In addition, keratin IPs modulate the cell's response to specific pro-apoptotic signals, control of cell and tissue growth, and the routing of membrane proteins in simple epithelia. Now it its ninth year, this project is centered around keratins 16 and 17, which are constitutively expressed in all epithelial appendages and induced whenever skin tissue is subjected to injury, UV exposure, and other challenges, as well as in diseases such as psoriasis and skin carcinoma. During the next period we will focus on the non-mechanical functions of K14-, K16-and K17-containing filaments in skin epithelia, with a particular emphasis on epithelial cell survival (Aim1), control of epithelial cell growth through regulation of protein synthesis (Aim 2), and the characterizationof their regulation in vivo (Aim 3). The proposal draws substantially from the consequences associatedwith lack of keratin 17 in mouse, which results in hair cycling defects secondaryto the untimely apoptosis of hair matrix epithelial cells, and in embryonic wound closure defects correlatingwith smaller size of activated epithelial cell at the wound edge. Because the K17 null phenotype is mitigated by the presence of keratin16 and the newly discovered keratin17n, we will also produce a mouse strain enabling the temporally- and spatially-controlled inactivation of the K7n-K17-K16 gene cluster (aim 4). As such, the project will further our understanding of keratin properties and function in health and indisease.